Automating Assessment of Contextualization of Care During the Clinical Encounter

Background: Large scale studies have demonstrated that when patients struggle with life challenges that
complicate their care (e.g., a lack of social support, competing responsibilities, or financial hardships),
health care providers can improve health care outcomes and lower costs if they attempt to identify these
“contextual factors” and address them in their care plan – a process termed “contextualizing care.” These
studies utilize a method of data analysis called “Content Coding for Contextualization of Care” (4C). 4C is
a labor-intensive process that requires human coders listen to audio recordings from a sample of medical
encounters, extract data from each patient’s medical record, and then track whether identified contextual
factors have been addressed. It has enormous social value and commercial potential because it accurately
identifies care plans that mitigate social needs and avoid unnecessary care. To date, sharing 4C data with
health systems has led to significant improvements in care and a reduction in rates of hospitalization. The
manual 4C coding process, however, is time consuming and unscalable. The automation of 4C coding
utilizing natural language processing (NLP) would enable rapid scaling.
Objective: Build a prototype system that performs automated 4C coding of transcribed audio-recorded
medical encounters, and assess its accuracy at classifying whether care planning is contextualized,
utilizing a test dataset with human 4C coding as a gold-standard.
Method: We propose an iterative development and validation process, leveraging an existing dataset of
over 400 manually 4C coded transcripts from physician-patient medical encounters. Starting with 300
transcripts previously coded by our team and coding guidelines from the 4C training manual, we will first
develop automated techniques for extracting text features reflective of nuances in linguistic content and
discourse structure that disentangle contextualized care from contextual error, in turn facilitating
development of candidate classification models that emulate human 4C coding decisions. We will then
apply the models to the remaining transcripts to predict transcript- and utterance-level codes, comparing
these codes with the human-labeled gold standard to establish feasibility, analyze performance, and
assess the models’ performance when generalized to new clinical encounters.
Impact: Health care systems are under financial pressure to control costs through a reduction in both
preventable hospitalizations and overuse and misuse of medical services. This phase 1 STTR will establish
the feasibility and technical merit of automated 4C coding to provide a low cost, scalable strategy for
accurately measuring and facilitating clinical performance that enhances value-based care. Such
technology is especially timely as audio recording visits is increasingly common as virtual scribes work
remotely to document medical visits, and audio recordings are provided as an information aid to patients.

Public health relevance
Well-intentioned treatment plans often fail because they do not take into account life challenges that patients face that complicate their care, such as a lack of manual dexterity or cognitive capacity to safely manage a complicated medication regimen. An established manual process of analyzing audio recordings made from a small sample of medical visits reliably identifies the kinds of errors clinicians make, helps them change their behavior, and improves outcomes and lowers costs, but is too labor intensive to scale. This project will utilize artificial intelligence methods and, specifically, natural language processing, to automate the process of identifying failures to adapt care to patient life context, introducing a scalable technology for facilitating high value care.